Closed-loop digital interventions through a remote clinical trials platform.

Project Summary / Abstract: Overall
The overall theme of this Roybal Center is to leverage technology to facilitate memory and cognitive function
so that cognitive decline may be prevented or delayed in older adults, and particularly those at-risk of
Alzheimer's disease and related dementias (AD/ADRD). The number of people in the world aged 60 years or
over continues to grow, which is accompanied by a comparable increase in those who will suffer cognitive
impairment. This age-related cognitive decline does not just lower the quality of life for the individual, but at
scale, it will impact every sector of society. Therefore, maintaining or improving cognition in aged adults, even
for a few months, could have an important effect at the population level. In order to reach such a large portion
of the population, the proposed Roybal Center will harness technologies we have recently proved beneficial in
older adults and further develop them to deploy iterative behavioral interventions that offer unparalleled
convenience and affordability. To achieve this, a Behavioral Intervention Development (BID) Core and an
Administrative Core will work together to conduct clinical trials and guide intervention development,
respectively. The BID Core will conduct Stage 0 through V studies in accordance with the multidirectional,
translational NIH Stage Model, to produce potent and implementable principle-driven behavioral interventions.
The Administrative Core will support the BID Core by monitoring the project science and compliance, handling
internal and external communication, managing scientific leadership, providing governance, financial oversight,
and infrastructure to promote transdisciplinary interaction and synergy among center components and
collaborators. The specific aims of each core are as follows. BID Core Aim 1. Assessment of efficacy and
effectiveness of behavioral interventions in a community setting. BID Core Aim 2. Refine interventions, assess
feasibility and initial efficacy in a research setting. BID Core Aim 3. Maintain, expand, and enhance Nexus: A
modern behavioral remote intervention platform. Administrative Core Aim 1. Maintain the Center's strategic
vision. Administrative Core Aim 2. Oversee BID projects. Administrative Core Aim 3. Facilitate
collaborative networks. The MPIs of the Roybal Center, Drs. Gazzaley, Wais, and Zanto, draw on their
extensive experience administering large, complex, collaborative, transdisciplinary grants and their proven
ability to take an idea for a behavioral intervention through all the NIH Stages of intervention development. The
MPIs have successfully collaborated for more than 15 years and are co-founders and directors of Neuroscape
at UCSF, a translational research center. Thus, the proposed Roybal Center will seamlessly integrate with their
pre-established method for following the NIH Stage Model to develop interventions and this new Center will
play a key role in guiding future behavioral interventions out of the lab and into people's homes.

Public health relevance
Narrative: Overall The increasing aging population is accompanied by a comparable increase in those who will suffer cognitive impairment, which impacts quality of life for the individual, and at scale, impacts every sector of society. Therefore, maintaining or improving cognition in aged adults at risk of dementia, even for a few months, could have an important effect at the population level. To achieve this, the Roybal Center will conduct Stage 0 through V pilot studies in accordance with the multidirectional, translational NIH Stage Model, to produce potent and implementable principle-driven behavioral interventions.